Decoding Exposure and Health Risks: Analyzing the Release of Nano- and Micro-Plastics from Plastic Food Containers into Water and Beverages

Project Summary
This project tackles a crucial public health concern: human exposure to nano- and microplastics (NMPs) released
directly from everyday plastic food containers, specifically reusable plastic cups, single-use water and soft drink
bottles, and takeaway coffee cups, made from four major polymer types, i.e., Polypropylene (PP), Polyethylene
Terephthalate (PET), Polyethylene (PE), and Polylactic acid (PLA). Growing evidence suggests that microwaving,
high-temperature storage, and other common uses of plastic containers can release billions of microplastics and
trillions of nanoplastics into beverages. This study aims to quantify these releases and assess their potential
health risks. The research design includes three primary aims:
• Aim 1 will measure the release of NMPs from plastic containers under a variety of real-life
conditions, generating critical data on NMP concentration and particle characteristics in common
use scenarios. This aim will reveal how polymer properties and usage conditions influence release
quantities.
• Aim 2 will use in vitro and in vivo models to evaluate the biological effects of NMP ingestion on
human health, specifically looking at impacts such as inflammation, oxidative stress, and toxicity
to cells and organs. This aim will clarify how non-uniform particle shapes and sizes impact cellular
and organ responses, with potential biodistribution variations across tissues.
• Aim 3 will evaluate how everyday behaviors—such as microwaving, storing, and drinking from
plastic containers—affect NMP exposure, establish dose-response relationships for different
plastic materials, and assess health risks linked to long-term NMP exposure from water and
beverage consumption.
This project is innovative in its approach to assessing human exposure to NMPs released directly from plastic
food containers, a previously underexplored pathway. By using an advanced laser-based technique to generate
NMPs that reflect real-world variability in particle size and shape, the study aims to produce more accurate data
on NMP release, health impacts on cell toxicity and organ function, and consumer behaviors that increase
exposure. The outcomes will guide practical recommendations for manufacturers and consumers to reduce
health risks associated with NMP ingestion from everyday plastic use.

Public health relevance
Project Narrative This research will reveal how plastic containers release tiny plastic particles into food and drinks, expanding our understanding of direct human exposure to nano- and microplastics (NMPs). By examining the health effects of these particles, such as cell toxicity and organ impact, the study will provide crucial insights into the biological responses triggered by NMPs. In the long term, this knowledge can guide safer material choices and inform public health guidelines, aiming to reduce health risks and improve overall well-being.